Dynamics of Neurocognitive Development in ADHD and Young Adult Outcomes

PROJECT SUMMARY
The key focus of this proposal is to characterize developmental mechanisms in Attention-Deficit/Hyperactivity
Disorder (ADHD). ADHD is viewed as a neurodevelopmental disorder, yet most often identified in the
elementary school age years and frequently leading to further psychopathology and negative outcomes by late
adolescence and early adulthood. The project emphasizes the role of neurocognitive functions, particularly
elements of executive functioning such as working memory and supportive functions such as attentional
alertness, along with emotional features such as irritability. These are all hypothesized as component
mechanisms of ADHD symptom change and stability and potential drivers of outcomes. Addressing
mechanisms of change during development of psychopathology is directly in line with key program priorities.
The training goals of this F32 will develop the applicant's expertise in ADHD, in executive functioning and other
common cognitive functions associated with neurodevelopmental disorders like ADHD and autism spectrum
disorder (ASD), strengthen her readiness with advanced and complex statistical models, and support her
professional development and writing skills. This will build on her prior graduate school training in ASD and
position her to conduct work on the relations among neurodevelopmental conditions and developmental
mechanisms linking them during her career. The research aims dovetail with these training aims. Using a
recently completed longitudinal data set from the sponsor's lab, the applicant will conduct secondary data
analysis from a large community recruited, carefully characterized case-control cohort of youth recruited at age
7-12 and followed for over a decade in a lag-longitudinal design that now spans ages 7-20+ years. The first
aim will identify how changes in specific neurocognitive components are related to ADHD symptoms across
development using a denser and more enriched longitudinal data set than has been available heretofore. The
second aim will extend those results by evaluating differences in neurocognitive function at particular key
developmental timepoints in relation to social and other functional outcomes in young adulthood. The third aim
will extend that work further by evaluating hypotheses concerning selected family and environment factors that
might moderate the effect of neurocognitive function on ADHD outcomes. These analyses will capitalize on
training in ADHD, neurocognitive study of development, and statistical models in complex designs. The
research itself is innovative in the detailed testing of hypotheses regarding the role of executive and other
neurocognitive functions during a dynamic developmental period in ADHD and in linking these to
environmental moderators. The public health value should be significant in regard to further clarifying when
and where in development to provide remediation support for youth with ADHD regarding component
dimensions of functioning that appear to drive impairment and outcome.

Public health relevance
PROJECT NARRATIVE Attention-Deficit/Hyperactivity Disorder (ADHD) is associated with numerous negative outcomes in late adolescence and early adulthood. Neurocognitive functions such as executive functioning and emotional features such as irritability are component domains that appear to influence poor outcomes. This training grant will prepare a promising young scholar in the study of these important processes and will entail research that clarifies mechanisms of change in ADHD to inform better tools for remediation and care of troubled youth.